Functions of Lactoferrin Polymorphisms in an Oral Infection

DESCRIPTION (provided by applicant): Aggregatibacter actinomycetemcomitans (Aa) has been implicated as the causative agent of localized aggressive periodontitis (LAP), a severe form of periodontal disease that can lead to premature tooth loss in adolescents. This rapid form of periodontal disease affects more than 70,000 adolescents annually in the US alone. African-Americans have a 15-fold greater incidence of the disease than Caucasian-Americans making LAP a disproportionate burden on minorities and the poor. We recently have identified two new polymorphisms of the lactoferrin (Lf) gene that are involved in LAP. One polymorphic alteration occurs at the codon 11 (alanine/threonine) and the other is localized in the LPS binding region at codon 29 (arginine/lysine). Preliminary data suggests that genetic polymorphisms of Lf may play a significant role in determining an individual's susceptibility to the LAP. The research outlined in this revised proposal will test this hypothesis using a mouse model and focusing on the functional characterization of genetic polymorphisms of Lf. The specific aims of the research are to 1) Generate bigenic Lf-variants/Lf-knockout mice;2) Determine the anti-bacterial and anti-inflammatory activities against Aa colonization and infection in bigenic Lf-variants/Lf-/- and Lf-/- mice. The results of the proposed research will contribute to our understanding of the functional role of Lf polymorphisms in LAP and provide new approaches to prevention of this disease based on functional differences in single nucleotide polymorphisms (SNPs) in the Lf gene.

Public health relevance
PUBLIC HEALTH RELEVANCE: Aggregatibacter actinomycetemcomitans (Aa) has been implicated as the causative agent of localized Aggressive Periodontitis (LAP), a severe form of periodontal disease that can lead to premature tooth loss in adolescents. This rapid form of periodontal disease affects more than 70,000 adolescents in the US annually. African-Americans have a 15-fold greater incidence of disease than Caucasian Americans making LAP a disproportionate burden on minorities and the poor. Recently, we have identified two novel forms of genetic polymorphism of human lactoferrin. The alteration occurs at the codon 11 (Alanine (A)/Threonine (T) and other polymorphic alteration is localized in the LPS binding region of the Lf gene at the codon 29 (Argenine (R)/Lysine (K). Our preliminary results show that the A at position 11 and K at position 29 were predominantly found in LAP patients as opposed to T and R variants, respectively. The present proposal will test our hypothesis by focusing on the functional characterization of genetic polymorphism of Lf using a mouse model. Aggregatibacter actinomycetemcomitans (Aa) has been implicated as the causative agent of localized Aggressive Periodontitis (LAP), a severe form of periodontal disease that can lead to premature tooth loss in adolescents. This rapid form of periodontal disease affects more than 70,000 adolescents in the US annually. African-Americans have a 15-fold greater incidence of disease than Caucasian Americans making LAP a disproportionate burden on minorities and the poor. Recently, we have identified two novel forms of genetic polymorphism of human lactoferrin. The alteration occurs at the codon 11 (Alanine (A)/Threonine (T) and other polymorphic alteration is localized in the LPS binding region of the Lf gene at the codon 29 (Argenine (R)/Lysine (K). Our preliminary results show that the A at position 11 and K at position 29 were predominantly found in LAP patients as opposed to T and R variants, respectively. The present proposal will test our hypothesis by focusing on the functional characterization of genetic polymorphism of Lf using a mouse model. __SpecificAimsTextDelimiter__ A. Specific Aims: Our previous research identified two functional single nucleotide polymorphisms (SNPs) in human lactoferrin (Lf): an alanine/threonine (A/T) substitution at position 11, and a lysine/arginine (K/R) substitution at position 29. Preliminary results also demonstrate that A at position 11 and K at position 29 are predominantly found in localized aggressive periodontitis (LAP) patients while healthy subjects have the Lf-T/R variant (Velliyagounder et al., 2003; Jordan et al., 2005). Furthermore, the two recombinant Lf-variants, rLf-A/R and rLf-A/K, exhibited equivalent bactericidal activities against Aggregatibacter actinomycetemcomitans (Aa), even though rLf-A/R showed significantly lower activity against the Gram-positive species, Streptococcus mutans and S. mitis. However, rLf-A/R stimulated OKF6/Tert epithelial cells to synthesize five fold higher levels of human beta- defensin (hBD-3) mRNA than the rLf-A/K (see Preliminary Data; Figs. 3; 4) and hBD-3 has been shown to kill Aa (Feucht et al., 2003; Ji, et al., 2007). Our working hypothesis is that genetic polymorphisms of Lf may play a significant role in determining an individual's susceptibility to LAP disease. The proposed research will test this hypothesis and examine the mechanisms by which the SNPs influence LAP, using a mouse model to determine the functional characteristics of different Lf-variants (A/K, A/R, T/K and T/R). The proposed research has two specific aims. Specific Aim 1: Generate bigenic Lf-variants/Lf-knockout mice. To test our hypothesis, we will generate transgenic mice over-expressing Lf-variants in salivary glands. In order to create these mice, we will use a salivary gland specific expression vector, constitutive parotid secretory protein promoter Lama II (PSP-Lama II; Golovan et al., 2001a), to direct the tissue specific expression of the Lf-variants. Furthermore, to study the role of Lf-variants independent of the effect of the wild type mouse Lf protein (mLf), we will crossbreed the transgenic mice with Lf knockout (Lf-/-) mice (Ward et al., 2003) to generate bigenic Lf-variants/Lf-/- mice expressing exogenous Lf-variants but not endogenous Lf protein due to the null mutation in Lf gene. Specific Aim 2: Determine the anti-bacterial and anti-inflammatory activities against Aa colonization and infection in bigenic Lf-variants/Lf-/- and Lf-/- mice. The mouse model was demonstrated to be useful in the study of LAP. The development of LAP induced by oral inoculation of mice with Aa leads to the migration of leukocytes to periodontal tissues and, ultimately, to alveolar bone resorption (Garlet et al., 2005). Results of both in vitro and in vivo studies suggest that the prophylactic effect of Lf involves inhibition of the production of several cytokines, including tumor necrosis factor (TNF-α), interferon (INF-γ), and interleukin-1β (IL-1β), which are key mediators of the inflammatory response leading to toxic shock (Crouch et al., 1992; Machnicki et al., 1993). Hypothesis: Lf-variants play a major role in determining the inflammatory response and extent of alveolar bone loss due to Aa infection. To test this hypothesis, we will use bigenic Lf-variants/Lf-/- and Lf-/- mice, to compare the effectiveness of the different Lf-variants in inhibiting the colonization and pathogenesis of Aa. We will also use these five groups of Tg mice to compare the effect of different Lf-variants on the extent of alveolar bone loss in experimentally induced Aa infection. Finally, we will compare the antibacterial and anti- inflammatory mediator profiles due to Aa infection in bigenic Lf-variants/Lf-/- and Lf-/- mice. This will be the first study to directly examine the functions of Lf expressed in salivary glands and secreted in saliva. We expect the results to 1) clarify the role of Lf-variants in Aa infection and to determine an individual' susceptibility to LAP, and 2) to reveal novel molecular and biochemical targets that may have diagnostic and therapeutic implications in the management of LAP.